UIC Portal to Biomedical Research Careers (UIC PBRC) PREP

ABSTRACT

The UIC Portal to Biomedical Research Careers (UIC PBRC) proposal is an R25 grant
application to develop a comprehensive post-­baccalaureate research education program
(PREP) in the biomedical sciences at the University of Illinois at Chicago. UIC is noted for the
diversity of its student body, and we take great pride in giving talented and highly motivated
students from the broadest possible backgrounds the opportunity for achieving success and
excellence at all levels of higher education. The UIC PBRC PREP will identify and recruit eight
recent baccalaureate science degree recipients who are strongly motivated to pursue a PhD or
MD/PhD degree, but who would benefit from a year engaged in cutting-­edge research and
building their critical thinking and scientific communication skills to become competitive
applicants to top PhD and MD/PhD programs. UIC PBRC Scholars will be predominantly
recruited from the significant pool of recent underrepresented baccalaureates at UIC and five
partner universities: Chicago State University, Florida A & M University, Northeastern Illinois
University, Oakwood University, and Roosevelt University. UIC PBRC Scholars will participate
in an intensive, mentored research experience with a UIC faculty member, and will be provided
with individually designed academic programming and professional development activities.
Unique aspects of this program will be scholar participation in a rigorous critical thinking course
that includes scientific writing and oral communication exercises designed to enhance their
development as competitive research scientists and a multi-­level approach for mentoring,
including individualized near-­peer mentoring. These activities combined with the intensive
research experience will be strong preparation enabling UIC PBRC Scholars to enter and
succeed in top graduate programs nationwide. A broader impact of the UIC PBRC PREP will be
achieved through expanded interactions with our partner universities to exchange and
implement best practices for promoting the entry of underrepresented students into biomedical
careers.

Public health relevance
Project Narrative To address the national need of increasing diversity in our biomedical workforce, the UIC Portal to Biomedical Research Careers (UIC PBRC) PREP will identify and recruit recent underrepresented baccalaureate science degree graduates for a comprehensive research program in the biomedical sciences. This program will prepare these scholars for admission to and success in biomedical PhD or MD/PhD programs, with the long- term goal that these individuals join the nation’s biomedical workforce as research scientists.